Interrogating the necessity of neuronal contributions to SCA3

ABSTRACT
Spinocerebellar ataxia type 3 (SCA3) is a debilitating neurodegenerative disorder characterized by impaired
balance and coordination, and it currently has no effective treatment. SCA3 is the most prevalent dominantly
inherited ataxia and is caused by a CAG repeat expansion in the ATXN3 gene. Although ATXN3 is expressed
throughout the body, its’ aggregates cause dysfunction in specific cell types, including neurons and glia, in
vulnerable central nervous system regions. Previous research suggests that neurons play a crucial role in
driving SCA3, as overexpression of mutant ATXN3 specifically in neurons is sufficient to cause ataxic
symptoms in a mouse model. However, it is still unknown whether neuronal mutant ATXN3 expression is
necessary for SCA3, which could be key for therapeutic development.
To investigate this, our lab created a novel conditional “off” knock-in Atxn3cQ300/Q6 mouse model that allows for
the selective silencing of mutant ATXN3 in specific cell types. Validation of this model in the absence of Cre
expression, shows they exhibit the well-established SCA3 pathophysiological features of disease such as
progressive motor impairment, nuclear ATXN3 accumulation, and significant pathological and transcriptional
dysregulation in neurons, oligodendrocytes, astrocytes, and microglia. By breeding this model with mice
expressing neuron-specific Cre, we will determine whether neuronal expression of mutant ATXN3 is necessary
for the motor deficits and pathological signatures in neurons and glia.
These studies are expected to provide critical insights into the cellular mechanisms of SCA3, which could have
a direct impact on therapeutic development. Additionally, this project will provide me with extensive experience
and training in experimental design, bioinformatic data analysis, and scientific communication, which will
prepare me for a career as an independent scientific investigator focusing on neuron-glia interactions in
neurodegeneration.

Public health relevance
Project Narrative My research project seeks to define the necessity of neuronal expression of mutant ATXN3 in spinocerebellar ataxia type 3 (SCA3) using a novel conditional knock-in mouse model. By selectively silencing mutant ATXN3 in neurons and assessing the resulting motor deficits and pathological changes, I aim to elucidate the cellular mechanisms driving SCA3. This project will not only offer critical insights for therapeutic development but also equip me with valuable skills in experimental design, data analysis, and scientific communication essential for a career in neurodegeneration research.